Preclinical development of capsid assembly modulators for the treatment of chronic hepatitis B virus infection

PROJECT SUMMARY
Despite the availability of a safe and effective vaccine, there remains over 257 million people chronically
infected with hepatitis B virus (HBV) world-wide. Individuals with chronic HBV infections are at risk for
complications due to liver disease and liver cancer. Chronic HBV is currently managed with nucleos(t)ide
reverse transcriptase inhibitors (NrtI) which partly suppress HBV DNA replication, normalize alanine
aminotransferase levels (ALT) and slow disease progression. Front-line therapies, however, are not curative
and patients with chronic HBV exhibit poor off-treatment responses requiring life-long therapy. New antivirals
and immunomodulatory approaches are, therefore, needed to further suppress viral replication and provide the
conditions that are required for immune control known as a “functional cure”. One of the most promising
classes of compounds under investigation are the core protein allosteric modulators (CpAM) that block HBV
replication at multiple stages of the viral life-cycle. Here, we report on a best-in-class CpAM that exhibits potent
pan-genotypic antiviral activity. In this project, we propose to advance our lead CpAM into definitive INDenabling studies to ready the compound for Phase 1 clinical trials in healthy volunteers and chronic HBV
patients. Combination regimens that include a CpAM, antivirals possessing distinct mechanisms of action
and/or novel immunomodulatory agents will be evaluated in a mouse model of HBV infection in preparation for
Phase 2 development in chronic HBV patienst.

Public health relevance
RELEVANCE TO PUBLIC HEALTH Infection with hepatitis B virus (HBV) is typically self-limiting in otherwise healthy adults leading to an acute form of hepatitis. Vertical transmission or perinatal exposure during early childhood, however, results in a chronic life-long infection in the vast majority of infected individuals. Despite the presence of a safe and effective vaccine to prevent HBV infection, there are over 257 million individuals world-wide that are chronically infected. Persons living with HBV are at significant risk for complications due to liver cirrhosis and liver cancer. Although a sterilizing cure may not be possible for chronic HBV, due to the long-lived cccDNA species and relatively low turnover rate of infected hepatocytes, a shift towards complete immune control of viral replication termed a “functional cure” may be obtainable. A functional cure is an ideal endpoint for therapy and is defined as a chronically infected person that has achieved HBV DNA undetectable and has lost HBsAg expression (with or without seroconversion to anti-HBs antibodies). HBsAg loss occurs spontaneously in about 1% of patients/yr and is associated with a reduced risk of progression to cirrhosis and hepatocellular carcinoma (HCC). Several combination strategies are currently under investigation to accelerate the loss or silencing of cccDNA, as indicated by loss of HBsAg expression, including direct-acting antivirals, gene silencing of HBsAg expression and immunomodulatory therapies. Combinations of these agents are likely required to achieve a significant increase in functional cure rates for chronic HBV infection.